Yale Cancer Center Advanced Training Program for Physician-Scientists (YCC-ATPP)

The Yale Cancer Center Advanced Training Program for Physician-scientists (YCC-ATPP) was initially funded in 2019. It is a training program designed for YCC Hematology/Medical Oncology (Heme/MedOnc) fellows, with the aim of preparing them for careers as independent physician-scientists in cancer-related research. Given the remarkable advancements and opportunities in hematology and oncology, the involvement of well-trained physician-scientists who have expertise in both clinical aspects of the disease and fundamental cancer biology is indispensable for advancing medical research and enhancing patient outcomes.
While many of our Heme/MedOnc fellows aspire to become physician-scientists, they encounter various challenges, including limited dedicated research time, restricted funding opportunities, and difficulties in accessing personalized training and mentorship. The YCC-ATPP plays a vital role in nurturing the next generation of physician-scientists by addressing these challenges head-on. The YCC-ATPP leverages the abundant resources available at Yale and tailors its training to the specific needs of each fellow. Through the program, T32 fellows receive protected research time, funding support, and mentorship from a three-member Mentor Team dedicated to guiding their research projects and career development. Additionally, the YCC-ATPP offers specialized didactic courses, opportunities to mentor students in the lab, community outreach and engagement initiatives, and transitional pathways to help T32 graduates establish a strong foundation for their future careers as physician-scientists.
Since its initial funding in 2019, we have successfully recruited a total of 12 fellows. Among them, eight have already graduated from the YCC-ATPP Program, with four of them receiving promotions to Assistant Professor and three continuing their training in other programs. Currently, we have four trainees enrolled in the program. Furthermore, we have three trainees who are pursuing their PhD degrees through the Investigative Medicine Program, which receives partial support from the YCC-ATPP. All our fellows are highly committed to achieving their research goals, as evidenced by their achievements. Out of the 12 fellows, only one current trainee does not have publications, while the remaining 11 trainees have collectively published a total of 60 publications, including 56 peer-reviewed journal papers and four book chapters. Among these publications, 24 are first-author publications, comprising 22 peer-reviewed papers and two book chapters. Additionally, our trainees have received subsequent awards, honors, and have actively engaged in teaching, mentoring, leadership roles, community outreach, and other impactful endeavors. The YCC-ATPP significantly impacts the YCC by advancing research, improving patient care, fostering collaborations, and bringing innovative treatments to the clinic.

Public health relevance
Project Narrative: The Yale Cancer Center Advanced Training Program for Physician-scientists (YCC-ATPP) is specifically designed to prepare YCC Hematology/Medical Oncology (Heme/MedOnc) fellows for independent careers as physician-scientists in cancer-related research. Through the program, T32 fellows receive essential training and support including protected research time, funding, dedicated mentorship from a three-member Mentor Team, research projects, individual development plans, didactic courses, opportunities to mentor students, community outreach and engagement initiatives, as well as transitional pathways to facilitate the establishment of a solid foundation for their future careers as physician-scientists.